Atomic-level Structural-omics of Platelet Membrane Proteins via Multi-scale Structural Biology Approaches

PROJECT SUMMARY
Membrane proteins play a critical role in platelet function by relaying extracellular signals outside in. Changing
the quantity or quality of these proteins can alter platelet physiology and impact health. The native membrane
environment provides additional cues that regulate the protein structure and mechanism of action.
Cryogenic electron microscopy (cryo-EM) has revolutionized structural biology by solving high-resolution
structures of membrane proteins and large macromolecules from homogeneous samples. A recent
breakthrough in data processing, the "Build and Retrieve" (BaR) methodology, performs in silico purification
from large heterogenous cryo-EM datasets, making it feasible to obtain protein structures from crude
preparations in their native environments. Using Cryo-Focused Ion Beam (cryo-FIB) on whole cell sample
preparation provides opportunities to directly visualize macro-complex in situ. How the native environment
regulates platelet function at the near-atomic level will be uncovered by combining these technical advances.
The preliminary studies using cryo-EM coupled with BaR focused on proteins that are ~200kDa. It solved the
first unmodified integrin αIIbβ3 structure in inactivated and intermediate states at 2.76Å and 2.49Å with metal
ions, N-linked glycans, and a ligand preserved. A third structure identified a novel dimer conformation of αIIbβ3
at 2.61Å, which potentially indicates an unknown αIIbβ3 self-regulatory mechanism in the native environment.
The scientific goal of this application is to solve membrane protein structures from resting and activated
platelets from healthy donors without artifacts due to purification processes. Aim 1 (K99 phase) will focus on
extending the preliminary αIIbβ3 data to determine the in-situ dynamics of integrin activation. Aim 2 (R00 phase)
will focus on building the structural atlas of platelet membrane proteins using the combination of single-particle
cryo-EM, in-situ cryo-EM, and cryo-ET with the BaR method. This aim will start with a specific focus on
mitochondrial supercomplex and ATP synthase. Ultimately, solving the structures of membrane proteins in their
native environment will reveal conformations and interactions that govern protein function. Obtaining these
insights will pave the way for significant advancements in disease orientation, disease diagnostics, and
therapeutic interventions in patients with platelet disorders.
The career goal in this application is to set the trajectory for the candidate’s independent research program to
conduct highly innovative research to bridge the hematology and structural biology fields. The candidate will
acquire experimental training for in-situ cryo-EM studies and cryo-ET during the K99 phase. Working with the
mentoring team, this application outlines an intensive training plan to foster the further growth of the core
competencies (communication, critical thinking, professionalism, creativity, teamwork) for transitioning the
candidate into a well-equipped independent investigator in hemostasis and thrombosis field with a unique
combination of research skillsets and a highly innovative and scientifically promising research platform.

Public health relevance
NARRATIVE Platelet membrane proteins are critical in fulfilling platelets’ roles in physiological processes by actively sensing the surrounding changes and are subjectively modulated by the environment. A holistic understanding of this critical interaction between membrane proteins and their environment in resting and activated platelets will enhance our basic knowledge of platelet biology and physiology, paving the way for significant advancements in disease diagnostics and therapeutic interventions. The studies proposed in this application will identify the interaction network of platelet membrane protein complexes from their native environment using multi-scale cryo-EM imaging approaches with advanced data analysis.